Replication Of Chromosomes In Budding Yeast

Abstract
Our understanding of DNA replication and its relationship with chromatin structure, nuclear organization
and gene transcription has advanced significantly through the development of genome-wide assays. Most
genome-wide tools to study DNA replication utilize large populations of cells and report on the average
behavior of the population; as such, many infrequent or stochastic events that occur as the replication fork
progresses through chromatin are missed. Recently, we have developed novel methods to map DNA
replication with single-molecule and single-nucleotide precision. In this proposal we will apply this new
technology to understand how DNA synthesis can be completed when the replication machinery
encounters obstacles. We will specifically test how RNA/DNA hybrids and G-quadruplex DNA influence
the progression of DNA replication and whether DNA synthesis can be efficiently restarted downstream of
an impediment. In addition to understanding the progression of replication through chromatin, we will also
investigate how replication is competed during the process of termination. Using high-resolution assays,
we have uncovered a critical role for the DNA helicase Rrm3 in replication termination. We will further
define the role played by Rrm3 and test a novel hypothesis that Rrm3 may prevent catastrophic re-
replication of the genome.

Public health relevance
Project narrative Each time a cell divides it must produce an accurate copy of its genome. This process, termed DNA replication, is essential and defects in DNA replication can lead to mutations, chromosomal rearrangements and cancer. This project will use new technology to understand the molecular mechanisms that control how the genome is replicated.